Transformation of metal(loid)-bearing particulate matter and associated impacts on bioaccessiblity

PROJECT SUMMARY (Project 3: Jon Chorover, Robert Root, Mónica Ramírez-Andreotta)
Mine tailings wastes are continuously generated and deposited at the land-surface where they serve as point
sources for airborne particulate matter (PM). As mandated by the Clean Air Act, the U.S. Environmental
Protection Agency (EPA) has established regulatory standards for PM of <2.5 ìm (PM2.5) and <10 ìm (PM10)
that indicate the maximum PM concentration to be present in outdoor air irrespective of PM composition. The
health risks associated with PM from mine tailings (mt-PM) are greater than for most other sources because
they contain elevated concentrations of toxic metals and metalloids, such as arsenic, lead, cadmium, and zinc.
These toxic metal(loid)s occur as surface-adsorbed molecular species or as atoms co-precipitated into a wide
range of crystalline and amorphous structures. The local bonding environment of a metal(loid) in a given
particle – also known as its molecular speciation – is defined by its oxidation state, coordination number, and
nearest neighbor atom composition. These nanoscale characteristics change over the course of mt-PM
diagenesis because of weathering and local biogeochemical conditions. Furthermore, as tailings undergo
weathering, toxic metal(loid)s are enriched in smaller, neoformed particles that are more susceptible to
aerosolization than the originally-deposited mt-PM. The mt-PM also contain redox active species, such as iron,
that can generate reactive oxygen species in vivo. We hypothesize that weathering-driven alterations in
molecular speciation of metal(loid)s in mt-PM controls their bioaccessibility, bioavailability, and toxic effects
during inhalation exposure, which is the primary exposure pathway being studied in the UA DUST Center. We
further postulate that mt-PM transport into adjacent residential soils and into ecosystems subjected to wildfire
leads to increased human health risk for proximal communities. These communities are thereby subject to
accumulation of multiple sources of a contaminant in a single site (i.e., “toxic layering”). The Project 3 team will
isolate fine mt-PM size fractions from a sequence of Superfund sites, as well as PM from nearby residential
soils and wildfire-impacted ecosystems, to test these hypotheses using advanced analytical methods of PM
characterization coupled to a novel flow through in vitro bioaccessibility (IVBA) reactor design. Metal(loid)
molecular speciation will be characterized before, during and after IVBA reaction using synchrotron-based Xray
absorption spectroscopy (XANES and EXAFS), whereas other parameters (geochemistry, mineralogy, size,
shape, element distribution, etc.) will be measured using wet chemistry, X-ray diffraction, electron microscopy,
dynamic light scattering, and micro-focused X-ray fluorescence spectroscopy. Well characterized PM from
Project 3 isolations and laboratory syntheses will be provided to Projects 1 and 2 for their in vitro and in vivo
analyses, thereby enabling cross-center correlations among bioaccessibility, bioavailability, and toxic effects
and their relation to molecular speciation of PM.

Public health relevance
NARRATIVE (Project 3: Jon Chorover, Robert Root, Mónica Ramírez-Andreotta) Project 3 will improve our ability to assess environmental risk of exposure to particulate matter from mine tailings (mt-PM) formed in surficial weathering environments throughout the western U.S. and beyond. Airborne particulate matter from mine tailings (mt-PM) contains elevated concentrations of toxic metals and metalloids such as arsenic, lead, cadmium and zinc as a result of its origin and weathering-induced mineral transformations. Our studies are designed to establish relations between the detailed physical-chemical properties of mt-PM and the release into lung fluid of the particle-bound metal(loid)s that they contain.